Automated, in-line hexavalent chromium analyzer

Project Summary/Abstract
The proposed Phase II SBIR Project will convert our successful feasibility study into a prototype system
for in-line, autonomous monitoring of hexavalent chromium in drinking and ground water. The OndaVia
in-line analysis system consists of consumable cassettes containing necessary reagents and an instrument
that scans the sample to determine contaminant concentrations. Results are presented simply to the user—
with calibration-free analysis performed over a wide concentration range. This project represents a beach-
head market opportunity for a platform-technology capable of measuring a wide-range of metals in water.
As an innovator in advanced chemical analysis, OndaVia is positioned to be the provider of choice for
companies demanding fast, accurate water testing.
The specific Phase II goal is to develop, evaluate, and validate our innovative technology into an in-line,
autonomous chromate analysis platform, enabling Phase III commercial activities. During the preliminary
work, OndaVia demonstrated the feasibility of semi-continuous chromate analysis in real-world samples,
achieving a sub-5-ppb detection limit. Our auto-calibrating, modular system overcomes the challenges
faced by other in-line systems using an optical method coupled with an internal standard to determine
chromium concentration. With the capability to speciate chromate, and future potential to measure
arsenic, ammonia, and nitrate with the sample platform, OndaVia’s approach addresses the needs of
industry in the years to come.

Public health relevance
Project Narrative Clean water is necessary for a healthy society, yet we are faced with constant new concerns about pollution in our water sources—including ever-increasing threats from trace pollutants such as metals that are widely present in our water supplies. Carcinogenic compounds like hexavalent chromium are present in the tap water of 200 million Americans, yet our water managers, research scientists and government agencies do not have available the types of low-cost/high- performance analytical tools they need to adequately study and monitor water pollutants at relevant parts-per-billion levels. OndaVia’s goal for this SBIR Phase II project is to develop an in-line, semi-continuous hexavalent chromium analysis system that will provide a tool for scientists, engineers, and regulators across the water sector to monitor trace contamination automatically.